The Role of miR-142 in the Transformation of Clonal Hematopoietic Disorders into AML

Chronic clonal blood disorders such as myeloproliferative neoplasms (MPN) and chronic phase (CP) chronic
myelogenous leukemia (CML) may over time transform, respectively, into secondary (s) acute myeloid leukemia
(AML) and blast crisis (BC) CML, which are poorly responsive to currently available therapies, including
allogeneic stem cell transplantation. Thus, the availability of novel and more effective treatments is a true unmet
need for these patients.
MicroRNAs (miRNAs) are small non-coding RNAs that target messenger RNAs and regulate the corresponding
protein levels. MIR142, encoding miR-142, is a highly conserved “gene”, expressed at high levels in
hematopoietic cells and is involved in the development and function of myeloid, lymphoid and megakaryocyte-
erythroid progenitors. MIR142 has been found mutated and/or downregulated both in lymphoma and AML.
Furthermore, miR-142 knock-out (KO) causes impaired hematopoiesis in zebra fish and mice, with expansion of
hematopoietic stem and progenitor cells (HSPCs) and decreased hematopoietic output.
We recently demonstrated that miR-142 KO in mouse models with clonal myeloproliferative disorders (MPDs;
i.e., FLT3-ITD+ MPN or CP CML) prompts transformation into an AML-like disease and confers a significantly
shorter survival to these animals. Our data support a role of miR-142 deficit in deregulation of the metabolism of
clonal hematopoietic stem cells (HSCs), with a switch to higher levels of oxidative phosphorylation (OxPhos) via
increased fatty acid oxidation (FAO); these changes likely play a key role in the transformation of clonal HSCs
into leukemic stem cells (LSCs). We demonstrated that rescue of miR-142 deficit with a novel miR-142 mimic
compound (CpG-M-miR-142) reduced OxPhos levels and viability of LSCs, decreased LSC burden and activity
and prolonged survival of treated BC CML mice. Thus, the central hypothesis of this proposal is that the
understanding of the cellular and molecular basis of miR-142 downregulation and its impact on the
transformation of clonal MPD into aggressive AML-like disease will allow us to design and optimize novel
treatments to compensate for the miR-142 deficit and prevent and cure MPD transformation. We propose the
following Specific Aims (SAs): SA#1: To define the role of miR-142 deficit in the sAML/BC CML transformation.
SA#2: To dissect the molecular mechanisms through which miR-142 deficit contributes to sAML/BC CML
transformation. SA#3: To investigate the pharmacokinetic (PK), pharmacodynamic (PD) and therapeutic impact
of a synthetic CpG-M-miR-142 that will rescue miR-142 deficit in sAML/BC CML.

Public health relevance
Project narrative (relevance): Despite appropriate treatments, chronic blood disorders such as myeloproliferative neoplasms (MPN) and chronic myelogenous leukemia (CML) (called here collectively MPD) can transform respectively into secondary acute myeloid leukemia (sAML) or blast crisis (BC) CML, which are very poorly responsive to currently available treatments. This proposal seeks to understand the mechanisms through which deficit of a molecule called miR- 142 confers to the MPD cells a more aggressive clinical behavior that transforms them into sAML/BC CML cells. To address the unmet need for effective therapies for these conditions, we will also develop a novel drug called CpG-M-miR-142 designed to restore levels of miR-142 and hopefully to lead to a cure in these otherwise poor- risk patients.